Cellular and molecular basis of detection of osmolality in insect taste system

Project Summary
Ingesting food with very high osmolality can perturb internal osmotic balance and cause several
physiological disorders. The fruit fly, Drosophila melanogaster, consumes food with varying osmolality and
must therefore expend significant energy to maintain osmotic homeostasis. Hence it is imperative for flies
to avoid consuming foods with high osmolality. However, whether high osmolality deters feeding in flies
and, if so, the neurons and receptors in the fly taste system responsible for detecting high osmolality are
unknown. The proposed project seeks to define the role of osmolality in modulating the feeding behavior of
fruit flies. The proposed work will employ sophisticated genetic, electrophysiological, and imaging
techniques in fruit flies to investigate the neural and molecular basis for the detection of high osmolality by
the gustatory system. Aim 1 will define the behavioral and cellular basis for sensing the osmolality of food
in the fly gustatory system. The aim is supported by my preliminary experiments that demonstrate flies
have a lower preference for a sugar solution with higher osmolality compared to lower osmolality solutions
at the same sucrose concentration. I will perform gustatory behavior assays to determine if the effect of
high osmolality on feeding depends on the food source. I will perform further assays to investigate if high
osmolality affects food consumption as well. Additionally, by silencing individual neuron types present in a
taste sensilla followed by behavior experiments I will probe the role of different neuron types in feeding
aversion caused by high osmolality. Aim 2 will further investigate the gustatory neurons that regulate
osmolality-induced feeding behavior. My preliminary data suggest that high osmolality can inhibit sugar-
induced activation of gustatory receptor neurons (GRNs) responsive to sweet taste. I will perform
extracellular tip recordings, which assay action potentials in GRNs, to characterize the effects of high
osmolality on the activities of GRNs. I have also outlined calcium imaging experiments to examine whether
high osmolality inhibits sweet taste neurons cell-autonomously or whether activation of bitter GRNs and
mechanosensory neurons also underlies the suppression of sweet GRN activity by high osmolality. Aim 3
outlines experiments to determine if chloride channels are required for the suppression of appetitive GRNs
by high osmolality. This aim is supported by my preliminary findings that demonstrate that a volume-
activated chloride channel is required for the inhibition of sweet GRNs by high osmolality. I have outlined
tip-recording experiments to test if it is required for the inhibition of water GRNs by high osmolality as well.
Additionally, I have outlined experiments to test the role of other chloride channels in the suppression of
neuronal activity by high osmolality. The findings of this project would establish osmolality as an essential
component influencing insect feeding decisions. Additionally, this work will provide novel insights into how
aversive stimuli can deter feeding by inhibiting the activation of attractive taste pathways.

Public health relevance
Project Narrative Ingestion of a hyperosmotic diet can perturb the internal osmotic environment leading to various physiological disorders, making it imperative for animals to avoid such food. The aim of the proposed research is to reveal the cellular and molecular basis underlying the regulation of food intake by high osmolality in Drosophila melanogaster. The proposed study will elucidate a novel mechanism for inhibition of feeding by aversive stimuli by directly silencing the activities of attractive taste pathways and can have applications in controlling insect-disease vectors and insect pests.